Novel Epitranscriptomic Mechanisms in Metal Neurotoxicity

Abstract
Chronic environmental exposure to neurotoxic levels of the metal manganese (Mn) affects the basal ganglia
system and has been linked to the etiology of Parkinsonism. Within the basal ganglia (BG), Mn primarily
accumulates in the globus pallidus, resulting in dysregulation of the BG neural circuitry. As the most abundant
glial cells in the CNS, astrocytes are critical for healthy brain function and are highly sensitive to Mn toxicity as
the metal preferentially accumulates in astrocytes. For any neurotoxicological triggers, astrocytes are early
responders and undergo a process known as “reactive astrogliosis”, characterized by morphological, molecular,
and functional changes. In this context, increasing evidence suggests that Mn neurotoxicity elicits pro-
inflammatory responses in astrocytes. However, the fundamental molecular neurotoxicological mechanisms
regulating the transformation of an astrocyte's homeostatic phenotype from quiescent to pro-inflammatory and
the exact molecular regulators of astrocyte crosstalk with neurons and microglia in metal neurotoxicity remain
enigmatic. In the emerging field of epitranscriptomics, the role of N6-methyladenosine (m6A) RNA modification,
under the dynamic control of N6-methyltransferases, demethylases, and readers (m6A mRNA-binding proteins),
in neurodegenerative diseases (NDs) is currently being explored. We recently obtained exciting new data
showing that the m6A reader protein YTHDF2 is specifically downregulated by Mn in cultured human astrocyte
cells and primary murine astrocytes as well as in animal models. Functional loss- and gain-of-function studies
reveal an anti-inflammatory role for YTHDF2 in Mn-stimulated astrocytes, leading to a novel hypothesis that
YTHDF2 may be a critical regulator impacting Mn neurotoxicity. Additional mechanistic studies identified SEK1
mRNA as a direct target of YTHDF2 and also discovered the ability of YTHDF2 to suppress the SEK1/JNK/c-
Jun pro-inflammatory signaling axis and subsequent production and secretion of selected pro-inflammatory
mediators in reactive astrocytic cultures. Very recently, we also observed a significant increase in the m6A
readers YTHDF1 and YTHDF3, which can boost the translation of their respective targets. Thus, the following
specific aims will be pursued to further expand our novel findings: (i) elucidate in animal models if chronic Mn
exposure dysregulates YTHDF proteins in astrocytes, and whether this dysregulation contributes to Mn
neurotoxicity by disrupting neuroimmune homeostasis; (ii) elucidate the pro-inflammatory signaling mechanisms
underpinning YTHDF dysregulation in activated astrocytes during Mn neurotoxicity in animal models; and (iii)
validate YTHDF proteins as key regulators of astrocyte-mediated immune and neuronal dysfunction in Mn
neurotoxicity. Overall, we anticipate that our proposed studies will provide novel mechanistic insights into
reactive astrocytic activation and neuroimmune interactions in metal neurotoxicology and will offer novel
therapeutic targets to dampen the neuroinflammatory processes in environmental factor-related
neurodegenerative diseases.

Public health relevance
Narrative: Exposure to environmental chemicals, including metals, pesticides, and other pollutants, plays a major role in the pathologic and behavioral consequences of many neurodegenerative diseases (NDs) including AD and PD. Given our exciting preliminary finding that environmental neurotoxic metal manganese (Mn)-induced post- transcriptional or epitranscriptomic modifications of astrocytic mRNA trigger pro-inflammatory signaling in astrocytes, we propose to further characterize the molecular neurotoxicological mechanism of astrocytic epitranscriptomic changes in inflammatory and neuronal dysfunction in animal models of Mn neurotoxicity. Our study will provide new insights into the neuroinflammatory pathogenesis of astrocytes and may offer new treatment strategies to slow down the initiation and progression of environmentally linked NDs.